Administrative Core

ADMINISTRATIVE CORE: ABSTRACT
The University of Arizona Cancer Center (UACC) Administration oversees all administrative functions that
support the Center’s research infrastructure, Members, and Research Programs. UACC Administration plays a
vital role in supporting the Center’s mission, vision, and strategic priorities in alignment with the Center’s
Strategic Plan by providing comprehensive support services that enable effective communication and
coordination among the Senior Leadership, Members, staff, and institutional stakeholders. Through these
efforts, Administration drives collaboration and maximizes the quality of science conducted by the Center’s
three Research Programs while also advancing scientific impact through Community Outreach and
Engagement, Cancer Research Training & Education Coordination, and Shared Resources. Under the
direction of the Associate Director of Administration, 22 FTEs are organized within six administrative units:
Human Resources, Research Services, Finance, Communications, Facilities Management, and Development.
These units are responsible for ensuring the efficiency and efficacy of UACC’s research infrastructure,
including oversight of all Cancer Center Support Grant activities and reporting; facilitation of strategic planning
efforts; organization of programmatic and Center-led research meetings, retreats, and symposia; management
of research support services (i.e., Shared Resources, seed funding, space, grant support services);
administrative support of UACC training and educational activities; and coordination with clinical research
leadership. UACC Administration provides the expertise, knowledge, and skills to assure quality and
consistency of operations while also conducting rigorous evaluations of progress toward the goals and
objectives as outlined in UACC’s 2020–2025 Strategic Plan. UACC Administration continually refines and
improves processes and policies to ensure centralized, cost-effective services. UACC Administration currently
supports 151 Members, spanning 11 colleges and 36 departments across the University of Arizona, with a
funding portfolio of more than $34M. During the project period, UACC Administration facilitated the award of
$2.7M in 15 NCI supplements and more than 75 seed funding awards garnering nearly $11M in extramural
funding.